High Mechanical Shear Stress-Induced Neutrophil Dysfunction in Mechanically Assisted Circulation

Project Summary
Millions of Americans are affected by heart and lung diseases. Mechanically assisted circulation (MAC),
including mechanical circulatory support (MCS) with ventricular assist devices (VADs), extracorporeal
membrane oxygenation (ECMO) and cardiopulmonary bypass (CPB), is routinely implemented to treat patients
with advanced heart failure (HF) or respiratory failure or cardiac surgery. Recent data shows that
approximately 85% and 75% of patients supported with continuous flow VADs (CF-VADs) are expected to
survive 12 and 24 months, respectively, which are close to the survival rates of heart transplant patients.
ECMO use expanded rapidly over the last decade. While these device-based therapies save many patients'
lives and improve their quality of life, infections are a common postoperative complication in these patients and
are associated with increased morbidity and mortality. It is critical to understand the risk of infections in patients
receiving CF-VAD or ECMO support and its underlying mechanisms. Both contemporary CF-VADs and ECMO
systems are based on the rotary blood pump technology. The high-speed rotation of the impeller in a rotary
blood pump inevitably introduces a high mechanical shear stress (HMSS) on the blood cells flowing through
the pump. We believe that HMSS generated by the action of pumping in CF-VAD and ECMO therapies can
cause damage/injury to leukocytes, leading to their dysfunction which affects patients’ immune defense to
infection. Given the potential of CF-VAD and ECMO therapies for patients and the need to reduce the
significant complications associated with the devices, we propose to conduct a series of bioengineering
experiments to gain a better understanding of HMMS-induced neutrophil dysfunction. Three specific aims of
the proposed project are: (1) to characterize HMSS-induced structural, rolling/adhesion and phenotypical
alterations of neutrophils, and to establish the quantitative relationships between structural alterations of
neutrophils and HMSS over the range relevant to CF-VAD or ECMO therapies; (2) To assess phenotypical
profiles and dysfunction of leukocytes using an in vivo ovine model under low and high HMSS settings of CF-
VAD support; (3) To explore potential mechanisms of HMSS-induced neutrophil structural alterations relevant
to CF-VAD and ECMO therapies. Successful completion of this project will create new knowledge of HMSS-
induced leukocyte dysfunction associated with CF-VADs or ECMO systems. The new knowledge can be used
by engineers to develop less traumatic, next-generation biocompatible VADs and ECMO systems and by
clinicians to provide better postoperative management.

Public health relevance
Project Narrative While mechanically assisted circulation (MAC), such as mechanical circulatory support (MCS) with ventricular assist devices (VADs), extracorporeal membrane oxygenation (ECMO) and cardiopulmonary bypass (CPB), is routinely implemented to treat patients with advanced heart failure and respiratory failure, infections are a common postoperative complication in patients with MAC. Infections can develop into life-threatening events. Current MAC devices are based almost exclusively on rotary blood pump technology, in which an impeller rotating at high-speed pumps the blood, inevitably resulting in high mechanical shear stress (HMSS) that can damage blood components, including leukocytes. The goal of this project is to gain a better understanding of HMSS-induced neutrophil dysfunction associated with MAC through quantifiable measurements with well- controlled experiments. This knowledge can be used by clinicians to better diagnose and treat patients, and by engineers to develop less traumatic, next-generation biocompatible devices for MAC therapies.